Benefits and Harms of Long-term Osteoporosis Pharmacotherapy: Impact of Treatment Length, Type, Switching, and Holidays

Project Summary
Sixty percent of older adults who start osteoporosis drug therapy (ODT) with an oral bisphosphonate (BP) have
long-term exposure (3 or more years with 80% or higher adherence). Although a minimum of 6 to 12 months of
BP treatment is required to reduce fracture risk, BPs have extended half-lives and can provide benefits long
after discontinuation. Clinical trials have identified little difference in fracture risk for women who stopped
versus continued BP after 3 to 5 years. Further, prolonged BP use has been linked to adverse events like
atypical femoral fracture (AFF). Thus, guidelines recommend a drug holiday (pause in therapy) for most
patients after 3 to 5 years of BP use. Patients at high fracture risk are recommended to continue BP or switch
to another ODT, like denosumab, teriparatide, abaloparatide, or raloxifene. Several critical gaps in knowledge
exist about the risks and benefits of long-term BP use, drug holidays, ODT switching on clinical outcomes and
adverse events, particularly in groups with limited representation in trials like men and nursing home (NH)
residents. This proposal has three specific aims: (1) Among community-dwelling older adults with at least 3
years of BP use, examine the effects of BP drug holidays and ODT switching on fractures, fracture sequelae
(e.g., death, entry into NH), and AFF. (2) Among NH residents with at least 3 years of ODT, compare the
effects of discontinuing versus continuing ODT on fractures/sequelae and patient-centered outcomes (e.g.,
functioning, pain); and (3) Develop and validate clinical prediction algorithms for osteoporotic fracture and AFF
to guide clinicians making decisions on whether to initiate a drug holiday. Our central hypothesis is that the
effects of long-term ODT strategies will be dependent on treatment length, type, and patient characteristics.
The rigorous studies we propose will use multinational linked administrative and clinical datasets. The study
population will comprise older adults aged 66 years or older in the US and Ontario, Canada who have at least
3 years of long-term ODT. Data for this study will come from 1) Linked, universal healthcare and medication
claims data for all people (community-dwelling and NH) aged ≥65 years in Ontario; 2) U.S. Medicare claims on
community-dwelling older adults; and 3) Electronic health record (EHR) data for up to 10,000 NHs linked to
Medicare claims. We will implement a validated data cleaning algorithm for osteoporosis medication claims
and novel rolling window method to capture long-term ODT. Time-varying propensity score approaches and
novel causal inference methods like target trial emulation will be employed. This project will generate critical,
generalizable evidence to guide long-term ODT, prevent fractures, and minimize AFF among older adults. This
research will directly address RFA-AG-22-018, the Appropriate Use of Drug Therapies for Osteoporotic
Fracture Prevention Pathways to Prevention Workshop Panel Recommendations 1 and 4, and Strategic Goal
C of the National Institute on Aging. Additionally, the project will create an international data partnership to
leverage EHR and universal healthcare data to answer emerging research questions on ODT.

Public health relevance
Project Narrative Osteoporosis drug therapy reduces fractures that cause disability, entry into nursing homes, and premature death among older adults, but long-term exposure to many treatments for osteoporosis has been linked to serious, rare side effects. Better understanding of the benefits and harms of different long-term osteoporosis drug therapy strategies will help to guide treatment decisions for older adults and ultimately improve patient health outcomes. Additionally, the proposed work will establish a unique multinational data partnership that can be re-used to conduct timely studies on the effects of osteoporosis drug therapy in older adults.